Natural History Study of the Complications Associated with Allogeneic HCT

The protocol is open to all subjects actively enrolled in an allogeneic hematopoietic stem cell transplantation (allo-HCT) protocol at the NIH regardless of gender, age or medical condition.It is is designed as a natural history study to prospectively review the medical records of these subjects. This study will include subjects of all ages. The length of a subject's participation depends on the primary protocol's schedule and the complications of interest being followed in this study. Primary Objective Characterize the infection-related and noninfectious complications associated with allo-HSCT, including incidence, clinical course cost and distribution within each NIH Clinical Center protocol. Secondary Objectives 1. Identify correlations between allo-HCT complications and the underlying disease for which the transplant is being performed. 2. Examine the correlation between laboratory immune reconstitution and functional immune reconstitution. 3. Identify the specific toxicities associated with the various immunosuppressive regimens used in the transplant setting